Nickel-pincer nucleotide enzymes

Project Summary/Abstract
The nickel-pincer nucleotide (NPN) cofactor is a recently identified coenzyme discovered in lactate racemase
(LarA) but found more widely in 2-hydroxyacid racemases and epimerases. Synthesis of the cofactor requires
the sequential action of three accessory proteins: LarB carboxylates the pyridinium ring at C5 and hydrolyzes
the phosphoanhydride of nicotinic acid adenine dinucleotide (NaAD), LarE is an ATP-dependent enzyme that
converts the two pyridinium ring carboxylates into thiocarboxylates either by sacrificial loss of a protein cysteinyl
sulfur atom or by a mechanism involving a [4Fe-4S] cluster with a non-core sulfide, and LarC inserts nickel
(forming C-Ni and S-Ni bonds) in a CTP-dependent reaction. Gene homologs encoding these four proteins are
widely distributed in microorganisms associated with the human microbiome and among human pathogens. The
long-term objective of the effort described here is to significantly advance our understanding of how
microorganisms, including pathogenic species, make and utilize the NPN cofactor. Two specific aims will
achieve this objective: (1) the components of the NPN biosynthetic pathways will be structurally and
mechanistically characterized and (2) new roles of the NPN cofactor will be characterized beyond its function in
lactate racemase. Investigations of LarB will define the structure of an NaAD- and CO2-bound variant by
crystallography and confirm the formation of a covalent cysteinyl-pyridinium intermediate by stopped-flow UV-
vis spectrophotometry. In vivo analyses will test the cellular ability to reverse the sacrificial loss of cysteinyl sulfur
from one type of LarE. The [4Fe-4S] cluster-containing version of LarE will be structurally characterized by
crystallography. The hypothesis for a third, persulfide-containing form of LarE will be evaluated. The structure
and dynamics of intact LarC will be solved by cryo-electron microscopy. Alternatively, the N-terminal domain of
LarC will be defined by crystallography (complementing the known C-terminal structure) to better delineate the
enzyme’s single-turnover, CTP-dependent mechanism of nickel insertion. Additional LarA homologs will be
structurally and functionally defined. Examples that tightly bind larger substrates will be used to probe open
questions regarding the NPN-dependent enzyme reaction mechanism. Other examples are predicted to contain
both NPN and an iron-sulfur cluster whose function will be investigated. In addition, non-LarA-like proteins that
bind NPN will be identified and characterized. The findings obtained through these efforts will greatly increase
knowledge of the synthesis and utilization of nickel-pincer nucleotide cofactors in bacteria, including those
important to human health, with implications for identifying potential antimicrobial drug targets.

Public health relevance
Narrative The study of lactate racemase and its newly discovered nickel-pincer nucleotide (NPN) cofactor is highly relevant to public health because the enzyme is present in many microorganisms associated with the human microbiome and in numerous pathogens. The racemase enzyme produces D-lactate that is required for biosynthesis of the cell walls and responsible for vancomycin resistance in some microorganisms. This project will elucidate the steps of NPN cofactor synthesis and define its roles in metabolism beyond lactate racemization.